NATIONAL INSTITUTES OF HEALTH (NIH), NATIONAL CENTER FOR ADVANCING TRANSLATIONAL SCIENCES (NCATS), THERAPEUTIC DEVELOPMENT BRANCH (TDB), GMP MANUFACTURE AND STABILITY STUDIES OF HBMP-6 PLASMID

GMP MANUFACTURE AND STABILITY STUDIES OF HBMP-6 PLASMID

Rare Diseases